Flexible Funding Model-Infrastructure Maintenance for State Manufactured Food Regulatory Programs in Massachusetts

Project Summary/Abstract
Through the Flexible Funding Model-Infrastructure Maintenance for State Manufactured Food
Regulatory Programs in Massachusetts, the MA Department of Public Health, Bureau of Environmental
Health, Food Protection Program (BEH/FPP) will maintain conformance with the most current version of
the Manufactured Food Regulatory Program Standards (MFRPS) as well as support coordinated
federal/state/local Human and Animal Food (HAF) emergency response efforts. Continued conformance
with the MFRPS will ensure that Massachusetts’ manufactured food regulatory program maintains best
practices for a high-quality regulatory program to reduce foodborne illness hazards in plants that
manufacture, process, pack, or hold foods. BEH/FPP will continue to regulate and inspect its 1,700 food
manufacturers statewide, including licensed and non-licensed facilities and firms under shellfish and
dairy cooperative program inspections. BEH/FPP will collaborate closely with federal, state, and local
public health partners, industry, and other stakeholders as well as with agencies and organizations in
food/feed manufacturing, distribution, and protection to support its technical and operational
foundation for MFRPS maintenance. Measures to meet goals and objectives will be carried out within
the framework of the US FDA cooperative agreement. BEH/FPP is committed, through its participation in
this cooperative agreement, to maintain and strengthen the efficiency and effectiveness of food safety
and protection in Massachusetts and beyond.

Public health relevance
Project Narrative Through this cooperative agreement, the Massachusetts Department of Public Health, Bureau of Environmental Health/Food Protection Program will maintain conformance with the most current version of the Manufactured Food Regulatory Program Standards (MFRPS) and will support continuation of the of FDA Food Safety Inspection Contract No.: HHSF223201810018C. The Massachusetts MFRPS Program will continue to ensure and maintain best public health practices for a high-quality regulatory program to reduce foodborne illness hazards in plants that manufacture, process, pack, or hold foods. The Massachusetts Food Protection Program is committed to maintaining and improving its services via the incorporation of training, data sharing, data analysis, communications, and development of best practices and other resources to support national capacity/capability development.